Enhancing Clinical Decision-Making in Modular Youth Psychotherapy

Project Summary. Youths receiving mental healthcare often have multiple disorders, distinctive treatment-
relevant personal and family characteristics, and problems that may shift during treatment. For these youths,
modular psychotherapies, in which providers select from a menu of therapeutic elements to build personalized
treatments, may be especially appropriate. One well-studied modular youth psychotherapy is Modular
Approach to Therapy for Children with Anxiety, Depression, Trauma, or Conduct Problems (MATCH). In some
trials with intensive, one-on-one expert support for element selection, MATCH significantly outperformed usual
care and evidence-based standardized psychotherapies; but in trials with less intensive (more practically
feasible) support, MATCH did not outperform usual care. This discrepancy highlights a key challenge of
MATCH and other modular psychotherapies: selection of treatment elements. Because MATCH allows any
number of sessions implemented in any order, a virtually unlimited array of treatment element sequences could
be selected. This flexibility supports personalization but may also impact the effectiveness of MATCH and
other modular psychotherapies, because it can be unclear which modules should be used when. As in other
modular therapies, clinicians using MATCH are asked to use clinical judgment and are provided with decision-
making guidance based on past literature and client weekly assessments. But research has shown that
statistical decision-making models using archival data very often outperform clinician judgment. Currently, no
modular youth psychotherapies employ data-driven statistical models to inform decision-making. This is
understandable: no such models are currently available. The proposed study will be an initial step toward filling
this gap; it will use statistical models of archival treatment data to provide decision-making guidance in modular
youth psychotherapy, aimed at enhancing its efficiency and effectiveness. Per NIMH Priority 3.2, the proposed
project will inform “tailoring existing interventions to optimize outcomes” by “reanalyzing… aggregated clinical
trials” using “computational approaches… to facilitate clinical decision-making”. Specifically, the project will
aggregate data from six MATCH trials (N=602, ages 6-15), to: model short-term between-person and within-
person associations between use of each treatment element and subsequent symptom change at different
stages of treatment (Aim 1); use statistical learning to identify moderators of these associations between
elements and subsequent symptoms (Aim 2); and, in a holdout sample, test whether agreement between the
model recommendations and youths’ treatment course predicts long-term treatment outcomes (Aim 3). To
inform future development of clinical decision guidance tools (after the F31), clinicians will be interviewed about
how model-based findings might be used in clinical practice (Exploratory Aim 4). Ultimately, consistent with
NIMH priorities, this work may inform clinical decision making in youth psychotherapy in several data-driven
ways, with the goal of eventually enhancing the efficiency and effectiveness of modular youth psychotherapies.

Public health relevance
Project Narrative Broadly, the goal of the proposed project is to understand associations between specific therapeutic elements that are common in evidence-based youth psychotherapies (e.g., exposure; cognitive reappraisal) and symptom change in the context of modular youth psychotherapy, a well-tested flexible approach to psychotherapy. The project may enhance our understanding of which therapeutic elements are associated with better and worse outcomes, what factors (such as client clinical and demographic characteristics, and timing of module delivery) moderate these associations, and how findings from statistical models can be used to inform data-driven recommendations regarding which therapeutic elements to use when, tailored to fit young clients’ demographic and clinical characteristics. The findings of this project may inform decision-making in modular youth psychotherapies, potentially enhancing the efficiency and effectiveness of treatment.